Smartphone-based wound infection screener and care recommender by combining thermal images and photographs using deep learning methods

I. PROJECT SUMMARY: Smartphone-based wound infection risk screener and care
recommender by combining thermal images and photographs using deep learning methods
Chronic wounds, which affect 6.5 million patients in the US12 severely affect their quality of life, can take up to a
year to heal and re-occur in 60-70% of patients. Wounds often get infected (bacteria in wound), resulting in limb
amputations if not treated properly and on time1. In current practice, at the Point of Care (POC) (e.g., nurses
visiting patients’ homes and trauma sites), caregivers who are not wound experts have no way to diagnose
infections. Thus, they cautiously refer wounds suspected to be infected to clinics for debridement of dead tissues,
blood tests and infection diagnoses by experts57-60. However, referrals increase time before infected wounds are
treated, and the chances of limb amputation. Moreover, some referred wounds end up not being infected, wasting
patient and expert time and expenses (e.g., transportation)15-16. What is needed is a digital health solution
that enables non-expert wound caregivers to accurately detect infected wounds at the POC even without
debridement and provide standardized recommendations on evidence-based care and when to refer.
Smartphones equipped with high resolution cameras and the processing power to run machine/deep learning
methods are owned by most wound caregivers in the US56. Prior work by Goyal et al1 reported preliminary results
that show that infection can be detected from visual attributes such as increased redness in/around the wound
in a photograph using deep learning (accuracy 0.727± 0.025, sensitivity 0.709 ± 0.044, specificity 0.744 ± 0.05).
While promising, their results need to be improved and validated before clinical applications. Moreover, their
dataset included already debrided wounds with easily discernable infection cases, and they did not recommend
evidence based best care and decide when referrals to wound clinics were the best course of action.
Certain thermal image patterns are reliable indicators of wound infection20, and some models of smartphones
are now equipped with thermal cameras55. Our hypotheses are that 1) the accuracy of smartphone wound
infection detection can be improved by combining thermal images with photographs jointly analyzed
using a deep learning method 2) recommendations for actionable, evidence-based wound care and when
to refer can be generated using machine learning to standardize care provided by non-experts.
In response to NOT-EB-19-018, we propose research to investigate the capability and accuracy of detecting
infected wounds before debridement using deep learning methods applied to combinations of wound
photographs and thermal images and generating care and referral recommendations. We also propose
integration of the smartphone-based infection screener into our group’s existing wound assessment system7-9,
21-29 and validating it on new patients (N=100). Success on our proposed aims will increase the number and
objectivity of wound infections detected outside the wound clinic and fast-tracked to the clinic for treatment,
reducing the number of patients who require amputations. Our findings will apply to diverse wound types
including diabetic, pressure, arterial, venous, surgical61 and trauma wounds62, which all get infected.

Public health relevance
I. Project Narrative: Smartphone-based wound infection risk screener and care recommender by combining thermal images and photographs using deep learning methods. There is currently no method to diagnose infections in undebrided wounds at the Point of Care (POC) (e.g., in patients’ homes by visiting nurses), resulting in unnecessary referrals to wound clinics and increasing the time to treatment of infections and the likelihood of eventual amputation. To facilitate early and accurate detection of infected wounds at the POC, we propose a smartphone-based screener that jointly analyzes a combination of photographs and a thermal image of a wound using deep learning methods. Our proposed system will detect infections in both debrided and undebrided wounds and recommend evidence-based best care and when to refer infected wounds to experts, standardizing the quality of care provided by non-expert wound caregivers. 1|Page